Neural mechanisms of memory bias in adolescent social anxiety persistence and remittance

PROJECT SUMMARY/ABSTRACT
Symptoms of social anxiety rise dramatically at the transition to adolescence (ages 10-11), as peers increase in
importance. Failure to remit in social anxiety by mid-adolescence (ages 12-13) predicts increased symptom
severity, comorbid psychopathology, and diminished quality of life in adulthood. It is therefore critical to identify
factors that contribute to remittance or persistence of social anxiety during the transition to adolescence, as such
factors may serve as treatment targets. While much prior research on social anxiety persistence focuses on
threat-based processes, gold standard treatments that target these processes rarely result in remission. Thus,
there is an urgent need to develop a novel framework of investigation to identify new pathways to persistence
and corresponding intervention targets. While prominent theories suggest that biased memory for negative social
outcomes contribute to symptoms, such biases are relatively understudied in adolescent social anxiety. This
omission is significant because memory is reconstructive and fundamentally malleable, making it an ideal target
for treatment. Our preliminary data using behavior, fMRI, and neuromelanin-sensitive MRI (NM-MRI) to quantify
dopamine function, suggests interplay between dopamine system function and medial prefrontal cortex (mPFC)-
striatal connectivity promotes memory bias in adolescent social anxiety. Our overall goal is to apply this multi-
systems approach to the longitudinal study of adolescent social anxiety. Doing so may help identify sorely
needed biobehavioral targets for intervention during a key period of development, thereby preventing devastating
lifelong problems. To achieve this, we will assess social anxiety symptoms, dopamine system function and brain-
based functional connectivity associated with memory bias in 255 youth (10-11 years). Additional assessments
of symptom expression obtained at 6-month intervals as they transition to mid-adolescence (12-13 years) will
enable trajectory mapping. Our central hypothesis is that in the presence of high dopamine system function,
youth with biased recall for negative peer feedback and enhanced mPFC-striatal connectivity will be more likely
to persist in social anxiety versus those who remit. Specific aims are to (1) characterize longitudinal associations
between memory bias and social anxiety during a critical developmental period; (2) determine the extent to which
memory bias mediates the relation between mPFC-striatal connectivity and social anxiety symptom trajectories;
and (3) test moderation of brain-memory bias relations by dopamine system function. This proposal will advance
the field and provide novel treatment targets by characterizing the contribution of memory bias to adolescent
social anxiety persistence and remittance and its neural mechanisms. Innovative features are a focus on
understudied mechanisms (memory) in a key age (10-13 years) using multiple imaging modalities including NM-
MRI. Our project is significant because it is a critical first step towards providing the right treatment (based on
neural mechanisms) to the right youth (those who persist in social anxiety), at the right time (early adolescence,
before social anxiety becomes intractable).

Public health relevance
PROJECT NARRATIVE Because social anxiety that persists into mid-adolescence predicts lifelong negative mental, social, and economic outcomes, there is a critical need to identify the behavioral and neural mechanisms by which youth remit vs. persist in symptoms. The goal of this longitudinal project is to characterize the brain-based mechanisms by which biased memory for negative social experiences contribute to adolescent social anxiety persistence and remittance. Given gold standard treatment rarely results in remission, these results will pave the way to develop much-needed novel interventions, tailored to a key period of development, that prevent devastating lifelong consequences.